Age, period, and cohort effects on gender differences in alcohol use and alcohol use disorders in 47 national, longitudinally-followed cohorts

Age, period, and cohort effects on gender differences in alcohol use and alcohol use disorders in 47
national, longitudinally-followed cohorts
Project abstract:
Available evidence suggests that, across the lifecourse, gender patterns in alcohol use and alcohol use disorders
are converging; however, (a) whether this convergence depends on developmental stage, (b) whether it is due
to more rapid increases among women compared with men or, conversely, more rapid decreases among men
compared with women, and (c) why it is happening all remain inadequately understood - representing a critical
knowledge gap. Indeed, intervention and prevention efforts require information about whether convergence is
limited to certain age groups, and most critically, why they occur. Further, potential increases in drinking among
women portend a potential public health crisis, requiring accurate forecasting of future burden. Without such
information, intervention and prevention efforts can be misplaced, focusing on the wrong age groups, or the
wrong mediating factors. Only data with sufficient variation both historically and developmentally can answer
foundational questions about diminishing gender differences in alcohol-related outcomes. Drawing from a
lifecourse perspective, the present project will leverage 47 longitudinal cohorts collected through the Monitoring
the Future (MTF) project, from 1976 through 2022, and apply rigorous age-period-cohort growth curve modeling
to illuminate: when in historical time and during what developmental periods from ages 18 to 45 gender patterns
have been converging; how gender patterns are converging (i.e. because women are increasing, men are
decreasing, or both), and why gender patterns are converging. To determine why we will examine an
unprecedented array of potential mediating factors including sociological trends in role transitions (marriage,
parenthood, education, residential independence, and employment), gender and societal attitudes, and
psychological factors (drinking attitudes and reasons, future intentions for partnership and parenthood, parenting
and marriage satisfaction). We will employ rigorous age-period-cohort growth models to accomplish three aims:
(1) Test when in historical time and at what developmental age gender patterns in alcohol consumption, binge
drinking, and alcohol use disorder symptoms are converging or have converged; (2) Forecast future public health
burden of alcohol consumption, binge drinking, and alcohol use disorder symptoms and (3) Analyze sociological,
psychological, and attitudinal factors as potential mediators of gender convergences across historical time and
developmental age. Mediation will be estimated with novel methods developed for epidemiological applications
that overcome problematic assumptions of previous approaches. MTF data have been a key source of
information on substance use for more than four decades; studies have not to date been used to examine age-
period-cohort trends in gender differences in alcohol consumption. When, how, and why gender differences in
alcohol consumption vary across both the lifecourse and generations represents an important gap in the
literature; our proposed use of MTF data stands to be a seminal contribution.

Public health relevance
Age, period, and cohort effects on gender differences in alcohol use and alcohol use disorders in 47 national, longitudinally-followed cohorts Narrative: Gender differences in alcohol use and disorders are rapidly changing, and increases in alcohol use disorders among adult women are historically unprecedented, potentially portending the next public health crisis. Understanding how gender differences in drinking are changing in the new millennium is critical to prevention efforts, to focus on specific developmental age groups before alcohol use disorder symptoms arise, as well as treatment efforts, to improve access and services to women who may want to reduce or abstain from drinking. The present project stands to provide seminal evidence on gender differences in drinking with more than 40 years of national, multi-cohort longitudinal data that spans the course of young adulthood into middle adulthood with consistent measurement and design over time.